Calcium sensing and mitochondrial homeostasis

ABSTRACT
Calcium homeostasis is essential for cellular signaling and mitochondrial metabolic regulation, which are critical
for meeting the metabolic demands of various cell types. Calcium modulates cellular functions by binding to
calcium-sensing domains on numerous proteins. Many calcium sensors have multiple calcium binding domains
with varying affinities, allowing for diverse and graded signaling. Calcium concentrations vary across cellular
compartments, and the localization of calcium sensors facilitates subcellular and organelle-specific signaling.
Mitochondrial calcium flux is necessary for cell viability, especially in cells with high energy needs. Dysregulated
mitochondrial calcium leads to mitochondrial dysfunction, including ATP depletion, reactive oxygen species
production, loss of mitochondrial membrane potential, mitochondrial permeability transition pore opening, and
apoptogen release. These disruptions cause metabolic stress, triggering cell death and contributing to
pathological conditions. Mitochondrial-induced cell death plays a key role in degenerative diseases and other
cell death-related disorders. Understanding the molecular mechanisms behind mitochondrial stress responses
may identify new therapeutic targets for conditions linked to mitochondrial dysfunction. Recent studies have
shown that mitochondrial calcium uptake protein 1 (MICU1), located in the intermembrane space, regulates the
cristae structure through the mitochondrial contact site and cristae organizing system (MICOS) independently of
its established role in controlling mitochondrial calcium uniporter (mtCU) channel opening. This finding suggests
that calcium sensors may have additional molecular functions beyond mitochondrial calcium uptake. MICU
proteins, including MICU1, MICU2, and MICU3, regulate mtCU activity by controlling its open probability in
response to calcium. This regulation depends on calcium binding to EF-hand domains, with mtCU remaining
closed until cytosolic calcium levels reach a threshold. Knockout models for MICU proteins show abnormalities
in mitochondrial ultrastructure not observed in mtCU-specific knockout models, suggesting that MICUs regulate
other mitochondrial processes. The current research hypothesis is that MICU proteins influence mitochondrial
processes beyond mitochondrial calcium uptake. Over the next five year, our research program will focus on
three key questions: 1) do MICU proteins universally affect MICOS and mitochondrial ultrastructure? 2) what is
the cell type-specific regulatory role of MICU proteins in mitochondrial ultrastructure? 3) do MICU proteins
collaborate in regulating calcium sensing at mtCU and MICOS? By employing genetic, molecular, imaging, and
protein biochemistry approaches in cellular and mouse models, this investigation aims to clarify the molecular
mechanisms involved in mitochondrial calcium sensing and its effects on cellular physiology. This research
addresses critical gaps in understanding mitochondrial physiology, focusing on the interplay between
mitochondrial calcium sensing, mitochondrial calcium flux, and mitochondrial ultrastructure. The outcomes may
reveal new strategies for treating diseases related to mitochondrial dysfunction.

Public health relevance
PROJECT NARRATIVE Maintaining calcium homeostasis is crucial for cellular signaling and energy regulation, and disruptions in mitochondrial calcium sensing can lead to cell death and contribute to various human diseases. This research aims to uncover how calcium-sensing proteins regulate mitochondrial function, with a focus on identifying new therapeutic targets to address mitochondrial dysfunction in multiple pathological conditions. By exploring the molecular mechanisms behind calcium regulation in mitochondria, this work has the potential to advance treatments for a wide range of human diseases, including metabolic and neurological disorders.